A Navigator Program to Overcome Barriers to Hormonal Contraception

The overall rate of teen pregnancy in the U.S. has decreased during the past 10 years, mainly due to
increased use of hormonal contraceptives. However, it remains the highest amongst industrialized nations.
Research has shown that improving access to highly effective hormonal contraception results in increased
utilization and fewer unplanned pregnancies and abortions. Adolescents face significant barriers to access
including lacking knowledge of contraceptive options and how to obtain them, transportation issues, and
concerns over confidentiality. While there are strategies to address unplanned pregnancy prevention, none of
them focus on adolescent-specific barriers encountered outside the clinical context and how to overcome
them. My long-term career goal is to improve access to highly effective hormonal contraception for sexually
active adolescents. For this K23 application, I propose to develop a Contraception Navigator Program. This
type of model has been utilized in a variety of medical settings, including women’s health. However, our model
is unique in its focus on adolescent access to hormonal contraception outside of the clinical context. The
specific aims of this proposal are to utilize a mixed methods approach to: (1) Design a Contraception Navigator
Program that assists adolescents in choosing a contraceptive method, ascertains individual-level barriers to
access and then help mitigate these barriers to facilitate complete and timely access to contraceptive services;
(2) Develop an outreach strategy that effectively activates adolescents to seek help in obtaining hormonal
contraception through the navigator program; (3) Conduct a pilot test of the navigator program and outreach
strategy in one racially and socioeconomically diverse county within Indiana to demonstrate the feasibility of
the program model. We hypothesize that facilitating access to hormonal contraception through the
Contraception Navigator Program will ultimately result in increased use of hormonal contraception. We will
study the effectiveness of our outreach strategy at activating adolescents to seek out assistance via the
navigator program and the feasibility of the program within the adolescent population. The proposed research
will provide the necessary groundwork to compete for additional funding including applying for R03 funding to
develop an outreach strategy for pre-contemplative adolescents to broaden the reach of the navigator program
and R01 funding to assess the impact of the Contraception Navigator Program on access to birth control,
subsequent use of birth control, and ultimately its impact on rates of teen pregnancy. The proposed research
plan will also help me develop skills in patient-centered research methods, health communication/messaging,
health behavior change, and adolescent recruitment. I will also explore ethical considerations related to
conducting research on adolescent reproductive health. The work proposed in this K23 award will take place
under the mentorship of a multidisciplinary team of faculty with the required expertise to assist with not only my
development activities but also to accomplish the specific aims of my research proposal.

Public health relevance
Project Narrative While there has been recent success in decreasing the teenage pregnancy rate, the United States continues to have the highest adolescent birth rate of any industrialized country. This proposal seeks to build on previous research that has shown that removing barriers to contraception access leads to improved contraception use and lower unplanned pregnancy rates. Improving access to and subsequent use of hormonal contraception by teenagers has the potential to make a significant public health impact.